ASEHL Microbiology, Human Food Product Testing

ASEHL Project Summary-Micro SFY2021 The Microbiology Human Food Product Testing project will enhance our existing food pathogen testing within the state of Alaska. The selected products and targets represent Alaskan produced products that are distributed around the world. ASEHL plans to test a minimum of 100 Ready-To-Eat food samples for pathogens collected by the regulatory program, Food Safety and Sanitation (FSS). ASEHL will also bring on STEC confirmatory testing. If awarded funding for this track, the Food Safety & Sanitation Program (FSS) proposes to expand the current ready-to-eat surveillance program from 72 samples per year to 100, and include testing for pathogenic E. coli, listeria and salmonella. Samples of seafood produced in Alaska will be collected from retail outlets, as well as direct from processors, depending on the availability of the specific types of seafood products being sampled. Samples will be collected by trained FSS staff, and handled and transported according to procedures currently in place, which include maintaining sample integrity, aseptic technique and chain of custody, and are in conformance with the manufactured food regulatory program standards (MFRPS.) Samples will be collected throughout the year, approximately 25 per quarter, though the seasonality of some types of products may affect the schedule slightly. Samples will be collected from various geographical areas in Alaska, and will include communities with FSS office locations as well as sites where seafood processors are located.